Improving the Health of Workers and the Environment: Twenty Years of Toxics Use

DESCRIPTION (provided by applicant): Per Guidelines no Abstract required.

Public health relevance
Per Guidelines no Narrative required.